Functions of intracellular lipid-binding proteins

DESCRIPTION (provided by applicant): The vitamin A metabolite retinoic acid (RA) regulates gene transcription by activating two members of the nuclear receptor family of ligand-activated transcription factors: the retinoic acid receptors (RARs) and the peroxisome proliferator activated receptor?? (PPAR?). The partitioning of RA between its receptors is controlled by the intracellular lipid binding proteins CRABP-II, which delivers the hormone to RAR, and FABP5, which shuttles it to PPAR?. Consequently, the relative expression levels of CRABP-II and FABP5 determine the pathway through which RA activates transcription, the spectrum of genes whose expression is regulated by RA, and the biological responses to this hormone in different cells. RA is thus closely involved in regulation of multiple biological activities in health and in disease states including cancer and the metabolic syndrome. Studies described in this application will investigate the involvement of RA and its binding proteins and nuclear receptors in adipocyte biology and in regulating mammary carcinoma growth. Specifically, we propose to: 1) understand how RA maintains the phenotype of preadipose cells and to examine whether inhibition of adipogenesis by RA contributes to the remarkable ability of the hormone to counteract diet-induced obesity; 2) investigate the possibility that development of some cancers originates from improper RA signalling derived from dysregulation of the FABP5/CRABP-II ratio, especially arising from upregulation of FABP5 in tumors. We propose to shed light on the mechanisms that lead to increased expression of FABP5 in mammary tumors, examine whether FABP5 functions as an oncogene, and explore the possibility that downregulation of FABP5 will divert RA from PPAR? to RAR to inhibit tumor growth. PUBLIC HEALTH RELEVANCE: The vitamin A metabolite retinoic acid (RA) regulates gene transcription by activating two types of transcription factors: the retinoic acid receptors (RARs) and the peroxisome proliferator activated receptor ? (PPAR?). The partitioning of RA between these receptors is controlled by two RA-binding proteins, CRABP- II, which delivers the hormone to RAR, and FABP5, which shuttles it to PPAR?. Hence, the relative expression levels of CRABP-II and FABP5 determine the pathway through which RA activates transcription, the spectrum of genes whose expression in regulated by RA, and the biological responses to this hormone in different cells. By activating its dual transcriptional pathways, RA is closely involved in regulation of multiple biological activities in health and in disease states including cancer an the metabolic syndrome. Studies described in this application will investigate how RA and its binding proteins and nuclear receptors regulate the formation of fat cells and the molecular mechanisms by which the hormone controls the growth of breast cancer cells. The results of these studies are expected to shed light on fundamental issues in vitamin A biology and to point at novel strategies for treatment of obesity-associate diseases and of some cancers.

Public health relevance
The vitamin A metabolite retinoic acid (RA) regulates gene transcription by activating two types of transcription factors: the retinoic acid receptors (RARs) and the peroxisome proliferator activated receptor ? (PPAR?). The partitioning of RA between these receptors is controlled by two RA-binding proteins, CRABP- II, which delivers the hormone to RAR, and FABP5, which shuttles it to PPAR?. Hence, the relative expression levels of CRABP-II and FABP5 determine the pathway through which RA activates transcription, the spectrum of genes whose expression in regulated by RA, and the biological responses to this hormone in different cells. By activating its dual transcriptional pathways, RA is closely involved in regulation of multiple biological activities in health and in disease states including cancer an the metabolic syndrome. Studies described in this application will investigate how RA and its binding proteins and nuclear receptors regulate the formation of fat cells and the molecular mechanisms by which the hormone controls the growth of breast cancer cells. The results of these studies are expected to shed light on fundamental issues in vitamin A biology and to point at novel strategies for treatment of obesity-associate diseases and of some cancers.